ELSI.hub: National Center for ELSI Resources and Analysis

ELSI.hub (a National Center for ELSI Resources and Analysis) is a collaboration between Stanford University,
Columbia University and partners at the Hastings Center and Harvard University, whose mission is to enhance
the production and use of ELSI research by the ELSI community and other stakeholders. The goal of
ELSI.hub is to serve as a locus for resource sharing and community building to enhance the production,
sharing, and use of research on the ethical, legal, and social implications of genetics and genomics (ELSI
research), using the “knowledge to action” conceptual framework which highlights facilitators of and barriers to
knowledge sharing and use. ELSI.hub will be guided by the principles of responsiveness, inclusion,
adaptability, rigor, transparency, and open access. It will build in responsiveness to community needs,
focusing on ELSI researchers, and incorporating NHGRI and stakeholder input to prioritize services. ELSI.hub
will include a broad range of stakeholders of ELSI research by making personal and institutional connections to
solicit input, facilitate contribution and enhance dissemination. Our team brings over two decades of
experience in engaging a broad range of stakeholders in ELSI research and translational genomics through
NHGRI-funded initiatives focused directly on ELSI research and training, including two national Centers for
Excellence in ELSI Research (CEER) and a T32 Training Grant in the Ethical, Legal and Social Implications of
Genetics and Genomics Research. Our team is further strengthened by the institutional support of the Stanford
Center for Biomedical Ethics, internationally-known bioinformatics expertise and robust infrastructure, and the
Division of Ethics in the Department of Medical Humanities and Ethics at Columbia University. The specific
aims of ELSI.hub are:
· Aim 1: Create a platform to identify, collect, index and share ELSI research products
· Aim 2: Provide analytic functions of curation and synthesis of ELSI research on key topics, and
mapping the ELSI field
· Aim 3: Convene a broad base of stakeholders with relevant expertise to contribute to the development
of ELSI.hub resources and to address emerging ELSI questions on genomics research
· Aim 4: Engage in outreach, dissemination and training to support the contribution to and development
and use of ELSI.hub resources

Public health relevance
The goal of ELSI.hub, a National Center for ELSI Resources and Analysis, is to serve as a locus for resource sharing and community building to enhance the production, sharing, and use of research on the ethical, legal, and social implications of genetics and genomics (ELSI research).